BCCMA: Foundational Research to Act Upon and Resist Conditions Unfavorable to Bone (FRACTURE CURB): A stitch in time saves nine!

Overall Research Strategy: To ensure aging Veterans remain active and mobile with as little musculoskeletal
pain as possible, new approaches to the prevention of osteoporosis and promotion of timely bone regeneration
following a fracture are necessary. This collaborative research study brings together a group of VA investigators
with diverse perspectives, insights, models, and techniques, to synergistically attack a major clinical problem
that leads to high morbidity and mortality among Veterans, a bone fracture. The overall research strategy of each
integrated project is to use pre-clinical models of a disease that either weakens bone or delays bone repair, to
investigate novel ways to utilize or enhance the ability of parathyroid hormone (PTH) to promote bone formation,
and to assess disease and treatment effects on bone in a unified, stringent manner. Already under-diagnosed
and under-treated, osteoporosis is likely to increase the number of fragility fractures being treated at VA hospitals
without novel tools for early detection and novel treatment strategies that circumvent the rare but devastating
side effects of current therapies that inhibit bone loss. Addressing this unmet clinical need, the overall aims are
to identify therapeutic strategies to improve bone health among Veterans and to enhance the bone anabolism of
PTH signaling. The collaboration will address this overarching hypothesis: health problems disproportionately
affecting Veterans activate signaling pathways that increase bone resorption, suppress bone formation, or
impede the transition of cartilage to bone in a fracture callus such that improvements in the clinical management
of osteoporosis lie in understanding how these health problems hurt bone health.
Project Research Strategy: The traditional clinical standard of care for fracture prevention, is to screen for
osteoporosis late in the course of the disease, after bone has been denuded and fracture is imminent, before
resorting to anti-osteoporotic pharmacotherapies. Such therapies however, are inefficient at regenerating lost
bone, and bone quality, an important aspect of load bearing strength, often remains deficient. Thus, the clinical
standard of care is frequently inadequate and many patients ultimately go on to sustain a fracture, irrespective
of therapy. Compounding the problem, anti-resorptives (especially bisphosphonates) have significant immediate,
as well as rare, but serious long-term side-effects, making for poor compliance and refusal to initiate therapy.
Given this array of issues associated with late drug intervention, this project will investigate whether “a stich in
time, saves nine”, by examining if early prophylaxis using anti-catabolic drugs, anabolic drugs and a non-
pharmacological nutritional supplement, to prevent bone loss from occurring early in the etiology of the disease,
is more effective at preventing bone fracture than late therapy after bone has already been denuded and
regeneration is more difficult. We will study two maladies associated with increased fracture incidence and that
disproportionally affect Veterans. 1. Postmenopausal Osteoporosis, the archetypal bone disease of women and
an escalating problem in the VA healthcare system given women are the most rapidly increasing demographic.
2. Immune reconstitution bone loss (IRBL) which is caused by antiretroviral therapy (ART) used to treat HIV
infection. We will test in mouse models, the hypothesis that short-term intervention to preserve bone mass during
the early course of the disease, is superior to the traditional standard of care approach of withholding
interventions until the skeleton has been seriously denuded, before intervening with pharmacologic approaches
that are inherently inefficient at rejuvenating lost bone, and at best delay rather than prevent fractures. We will
leverage our VA collaborative partners to synergistically expand the depth and scope of our studies and allow
us to perform extensive state-of-the-art bone phenotyping to assess bone structure, quality and fracture
resistance in the two-model system. Should our studies reveal a significant advantage for early therapy, this
would support studies future studies in humans towards a change in the standard of care for fracture prevention.

Public health relevance
Almost 50% of women and 30% of men will suffer a fracture in their lifetimes. Fractures are a serious problem in aging Veterans and cause crippling disability requiring rehabilitation in up to 75% of individuals, loss of independence, and significant declines in quality of life. One year mortality after hip fracture in elderly veterans is 18% for women and 32% for men. Economic burden of fracture in the US is further projected to reach $25 billion/annum by 2025. As the largest integrated health care system in the US, the VA is on the front lines of fracture treatment and will have to absorb these ever-expanding medical needs and costs. In this project, we will use animal models to study two bone diseases that disproportionally affect Veterans, postmenopausal osteoporosis and bone loss cause by antiretroviral therapy against HIV. We will compare a novel therapeutic approach targeting early prevention of bone loss, to that of the current standard of care in which bone is regenerated after it has already been lost, a process that is only partly effective using currently available drugs.